A Pragmatic Trial of Parent-focused Prevention in Pediatric Primary Care

Goals of the parent project and proposed supplement: This is a request for an administrative supplement
to the Guiding Good Choices for Health study (4UH3AT009838, Kuklinski/Sterling), which tests the
implementation feasibility and effectiveness of embedding Guiding Good Choices (GGC), a group-based
prevention program for parents of early adolescents, in three large, integrated, geographically distinct healthcare
systems serving socio-economically diverse families. GGC reduced adolescent alcohol, tobacco, and cannabis
use, depression, and delinquent behavior in two previous randomized controlled trials. It also strengthened
parenting practices and parent-adolescent relationship quality, both broadly protective against behavioral health
concerns. GGC has the capacity to achieve population-level impact on adolescent health if made widely available
through pediatric primary care and can help fulfill the American Academy of Pediatrics' Bright Futures
recommendation that pediatricians offer developmentally tailored anticipatory guidance to all parents to support
their children's healthy development. The study team successfully recruited 1,975 adolescents empaneled with
75 pediatricians and delivered GGC to intervention arm families in the three healthcare systems. We are now
conducting follow-up assessments and beginning to examine key questions guided by the RE-AIM framework
(GGC Reach, Effectiveness, Adoption, Implementation, and Maintenance), including assessing the feasibility
and sustainability of GGC within each healthcare system, through qualitative interviews with HCS leaders,
pediatricians, and clinic staff. Administrative supplement: The COVID-19 pandemic that began in March 2020
delayed the GGC4H trial by 7 months and led to several additional time- and resource-intensive activities. We
are requesting supplemental funding to answer the key questions posed from the study's outset about
GGC's effectiveness and implementation feasibility when offered in pediatric primary care in a pragmatic trial.
We will use the supplemental funding to achieve the following aims: Aim 1: Complete planned follow-up
assessments with all adolescents, continue extraction of electronic health record data, and finish preparing
adolescent data from both cohorts for analysis of GGC effectiveness and cost-effectiveness. Aim 2. Complete
analyses of the feasibility and effectiveness of implementing GGC in three large integrated health care systems,
using the RE-AIM framework. With supplemental funding we plan to continue implementation analyses; evaluate
hypothesized reductions in the study's primary outcome of substance use initiation, secondary behavioral health
problems (e.g., substance use frequency, mood symptoms and diagnoses, delinquency), and exploratory
outcomes (e.g., emergency department and inpatient service utilization); and conduct cost-effectiveness
analyses evaluating GGC costs in relation to value gained. Evidence of feasibility and effectiveness in three
different healthcare systems should foster broad dissemination to increase public health impact.

Public health relevance
Pediatric primary care is an opportune place to deliver evidence-based parent education programs to prevent early substance use initiation, which often precedes adult substance use disorders and frequently co-occurs with other behavioral health problems like depression and delinquency that rapidly increase during the teenage years, often with lifelong negative health consequences. The parent study is a pragmatic trial testing the feasibility and effectiveness of providing Guiding Good Choices (GGC), a universal, evidence-based anticipatory guidance and education program for parents of early adolescents, in the course of routine pediatric primary care. Because additional study activities necessitated by the COVID-19 pandemic depleted budgetary resources, supplemental funds would allow us to complete follow-up assessments and answer key questions posed from the study's outset about implementation feasibility and effectiveness of GGC when offered in pediatric primary care.